ECHO Administrative Supplement - Neonatal Opioid Trials

Neonatal opioid withdrawal syndrome (NOWS) has increased more than fivefold since 2000. The
dramatic rise in NOWS has occurred in association with an increase in the use of opioids by pregnant
women. Little is known about the best methods for identification, monitoring, and treatment of affected
infants. The IDeA States Pediatric Clinical Trials Network (ISPCTN), which is part of the Environmental
influences on Child Health Outcomes (ECHO) Program, and the Neonatal Research Network (NRN) are
uniquely poised to address existing knowledge gaps associated with NOWS. The ISPCTN consists of >20
neonatal intensive care units and the NRN consists of >50 neonatal intensive care units. Both networks
have access to investigators, study coordinators, infrastructure, and participants for clinical trials. The
Duke Clinical Research Institute (DCRI) serves as the ECHO Coordinating Center and has extensive
experience in cohort studies and clinical trials in infants. The overall goal of our proposal is to use the
infrastructure of the ECHO Program and ISPCTN in collaboration with the NRN to initiate two clinical
trials to evaluate interventions to improve the care of infants and families affected by NOWS. Our
research team, led by Dr. Brian Smith at DCRI, will achieve this goal by implementing: 1) a clinical trial
protocol evaluating the optimal use of the Eating, Sleeping, Consoling (ESC) care approach on the length
of time until infants affected by NOWS are medically ready for discharge; and 2) a clinical trial protocol
evaluating whether an early stop weaning protocol for morphine in infants treated for NOWS will
decrease the number of days of opioid treatment. Using the highest research standards, we will
accomplish the task set out by the NIH to close research gaps in this critically important area.

Public health relevance
Well-designed research is urgently needed to examine the diagnosis, treatment and outcomes among infants with Neonatal Opioid Withdrawal Syndrome (NOWS). In partnership with the University of Arkansas for Medical Sciences (UAMS), the Duke Clinical Research Institute (DCRI) proposes to leverage its resources as the world’s largest academic research organization and Coordinating Center of the ECHO Program to carry out two clinical trials to evaluate interventions to improve the care of infants and families affected by NOWS.